Research Tested Intervention Programs/National Registry of Evidence-based Program

Agreement is for the management and execution of identifying, reviewing and rating evidence-based cancer control intervention programs through the National Registry of Evidence-based Programs and Practices (NREPP). In April 2003 NCI launched a new website titled [unreadable]Research Tested Intervention Programs for Cancer Prevention and Control.[unreadable] This website allows cancer control planners, program staff and researchers to access and acquire evidence-based cancer control programs and products. A feature of this website allows viewing a [unreadable]Consumer Reports[unreadable] style rating of the program that includes a description of the intervention impact, research integrity, dissemination capability, cultural, age and gender-appropriateness. Currently, SAMHSA serves as a central resource for identifying, reviewing, rating and disseminating information on evidence-based programs and practices to prevent and/or treat mental illness and addictive disorders. SAMHSA, in collaboration with NCI, will continue to guide and oversee the NREPP to identify and review evidence-based tobacco control, physical activity, sun safety, diet/nutrition, breast, cervical, and colorectal cancer screening promotion programs, cancer survivorship and other cancer control intervention programs that have efficacy data from peer-reviewed and funded research studies and where the efficacy data have been published in a peer-reviewed journal. NCI will be provided with all data collected for the review, copies of all the paperwork associated with the review (including copies of the original reviewers[unreadable] rating sheets) and finalized ratings for posting on the website.